Discovery Methods for Functional Immune Niches in Cancer

PROJECT SUMMARY
This study investigates the ‘reactive’ immune system in tumors, namely the cellular and molecular allies that
allow immunotherapies to work. The tumor microenvironment (TME) is a key biological structure that regulates
the effectiveness of cancer immunotherapies. Understanding its (rare) valuable components and niches as
compared to the inhibitory ones is critical to guiding next-generation immunotherapies. We hypothesize that
discrete niches exist in tumors that are the building blocks for reactive immunity and that these can be
found by co-labeling T cell activity (e.g. motility/synapse duration) and gene-expression signatures
together with unique innovative tools. By directly illuminating functional effector CD8 T cell states, we will
discover hidden features of their local microenvironment and define these in such a way to be widely applicable
in new settings.
This program is unique in applying and developing spatial transcriptomics together with genetic tools and
conventional cellular immunoassay methods to understand the critical phenotype-biology relationship between
critical T cell populations and their partners. The resultant discoveries will be formative for designing new ways
to boost anti-tumor immunity.

Public health relevance
PROJECT NARRATIVE Some patients’ immune system can be triggered with immunotherapies, leading to their cure and this relies upon the presence of a particular set of immune cells. This project will discover the nature of the home or ‘niche’ that supports these cells. In discovering this, we will discover how to build better anti-tumor immune systems and cure patients of their tumors.